Joslin-BIDMC Postbac Program in Diabetes and Metabolism

The United States struggles to cultivate the biomedical research workforce in the field of diabetes and metabolic disorders. To address this problem, we propose a new Joslin-Beth Israel Deaconess Medical Center (BIDMC) Post-baccalaureate Program in Diabetes and Metabolism to attract talented recent graduates to pursue further training and ultimately, careers in biomedical research in metabolic diseases. This program will leverage Joslin and BIDMC’s broad and deep expertise in diabetes and metabolism and a highly experienced cadre of mentors, who will provide participants with dedicated research experiences, mentoring, coursework, and professional development activities. The overall goal of our program is to provide participants with the scientific, technical, and professional skills they will need to pursue doctoral degrees and the inspiration to dedicate their talents to prevention, treatment, and cure of diabetes and related metabolic disorders. To effectively identify participants, our program will partner with the Biomedical Sciences Career Program, a Boston-based non-profit organization dedicated to providing mentorship and career development programs to promote successful careers in biomedical science. We will also reach potential applicants through the online platform, Handshake, and by working with career development and advising offices of universities in the New England region.

Public health relevance
The current pipeline of talent needs to be enhanced to adequately support progress in diabetes and metabolic diseases research. The Joslin-Beth Israel Deaconess Medical Center Post-baccalaureate Program in Diabetes and Metabolism will recruit recent post-baccalaureates; provide them with the scientific, technical, and professional skills they will need to pursue doctoral degrees; and inspire them to dedicate their talents for prevention, treatment, and cure of diabetes and related metabolic disorders. By partnering with the Biomedical Sciences Career Program and career development and advising offices of several universities, we will identify and recruit talented post-bac participants to join our program.